UC Davis Conte Center: Administrative Core

PROJECT SUMMARY – ADMINISTRATIVE CORE
The Administrative Core will provide administrative services to the UC Davis Conte Center, composed of five
projects and a Biostatistics Core, promoting strong fiscal management and oversight, and effective
coordination among the research groups as they pursue their interconnected and interdependent research
projects. The Administrative Core will ensure optimal communication across the Center and coordinate the
strategic communication of research results, as they become available, both within the Center as well as
externally to the scientific and broader community. As the public face of the Center, the Administrative Core
will be responsible for reporting progress to NIMH, as well as disseminating results through a diverse set of
mechanisms to the scientific community, other stakeholders, and the public at large. The Core will also be
responsible for the oversight of the training activities of the Center, working in coordination with the broad
range of pre- and post-doctoral training programs in neuroscience and related areas at UC Davis. The
Administrative Core will also oversee the evaluation of the Center's research, education, and outreach
activities. In order to meet these goals, we will pursue the following five specific aims: (i) Create an
organizational structure to expedite and coordinate research and provide financial and administrative oversight,
(ii) Foster internal Center communication and collaboration, (iii) Train the next generation of translational
neuroscientists, (iv) Engage the scientific community, local schools, mental health clinicians and the public at
large through a combination of targeted activities, and (v) Measure the impact of Center research and
dissemination activities.